Preparing Diverse Transfer Students for Research Careers in Neuroscience

Project Summary
An increasing number of undergraduates (~30% in the UC System) enter research universities
after 2+ years in community colleges. Transfer students are more likely to be underrepresented
minorities (URMs) or first-generation college students, and they seldom continue on to the PhD.
Although many of them express interest in research, they have little to no access to such
experiences at community colleges. Soon after matriculating at universities, they tend to opt out
of scientific research careers, particularly the idea of continuing to graduate school. In response
to this need and in the interest of increasing diversity in our population of neuroscience trainees,
here we propose a program to provide transfer students with the skills, mentorship, and
research experience to improve their chances of success in a research career. Our proposal
builds on the START program, which for three years brought cohorts of URMs and first-
generation transfer students to campus in the summer before they matriculated at UCSD. The
START program, and others like it, have resulted in improved outcomes for these students. Via
a partnership with local community colleges in collaboration with Academic Enrichment
Programs (AEP), the STARTneuro program will begin by identifying interested students before
they apply to UCSD. Accepted participants will then engage in a 10-week summer bridge
program, with intensive and immersive full-day lab training in neuroscience techniques, from
physiology to gene expression and function. Each student will also design and implement an
independent research project based on the summer modules. During the academic year,
students will meet regularly with faculty, be shepherded into lab internships, and be mentored in
applying for a summer research scholarship the following summer. A core group of faculty who
have demonstrated success mentoring undergraduates will provide the research experience
and stewardship necessary to ensure that participants can succeed in scientific research
beyond college.

Public health relevance
Project Narrative STARTneuro is a collaborative effort between UC San Diego Neurobiology faculty and the Academic Enrichment Programs Office along with articulation officers from San Diego area community colleges. The program aims to enhance diversity in neuroscience research through identifying, training, and mentoring transfer students from their matriculation at UC San Diego through the completion of their degrees. STARTneuro students will initially participate in an intensive 10-week summer research program followed by two years of course work, research training, mentoring, and skills development, ultimately translating to successful application to Ph.D. programs in neuroscience or a related field.